Genetic investigation of SARS-CoV-2 infection in oral and nasal tissues

Project Summary/Abstract
The COVID-19 pandemic has produced a global health and economic crisis. While the pandemic is gradually
being lessened by mass vaccinations, full control of this disaster is hampered by several ongoing problems
including: (i) resistance or poor access to vaccination; (ii) emergence of new more infectious viral variants; (iii)
“long COVID” symptoms in some patients; and (iv) incomplete understanding of the mechanisms of viral entry.
Thus, it remains important to identify additional methods of blocking infection and to improve understanding of
long-lasting symptoms so that these can be prevented and/or treated more effectively. SARS-CoV-2 infection
is transmitted via airborne droplets, and loss or alterations of taste and smell appear early in disease
progression, can occur in the absence of other symptoms, and serve as a diagnostic tool for COVID-19,
suggesting oral and nasal epithelia as primary viral targets. However, functional evidence for these epithelia as
primary infection sites is lacking, and the basis for chemosensory symptoms, and why these can persist after
disease recovery, remains poorly understood. In particular, whether COVID-19-associated taste abnormalities
are secondary to anosmia, infection of associated oral epithelia, and/or altered salivary secretion, or result from
direct or secondary infection of taste buds or nerves, is currently unclear. Addressing these questions in vivo at
the mechanistic level requires robust and genetically manipulable model systems. Mice provide an excellent
genetic system for human disease modeling, but cannot be robustly infected by wild-type SARS-CoV-2
because its spike protein does not efficiently bind the mouse ACE2 receptor. Existing human (h)ACE2-
expressing mice either express hACE2 in a transgenic, non-endogenous manner, or exhibit relatively weak
expression of hACE2 following knockin to the mouse Ace2 allele resulting in absence of clinical disease after
SARS-CoV-2 infection, limiting their use in mechanistic studies. The proposed studies will utilize powerful new
hACE2 conditional knockin mouse lines that support lethal SARS-CoV-2 infection and permit tissue-specific
Cre-mediated loss and gain of hACE2 function. Using these tools, we will: (i) determine whether hACE2
expression in oral and nasal epithelia is required and/or sufficient for lethal COVID-19 disease; and (ii)
elucidate the oral and nasal cellular mechanisms underlying taste dysfunction in COVID-19 disease. Combined
with human tissue validation, these studies will define the role of oral and nasal cells in COVID-19 disease and
reveal strategies to prevent or treat the disease by targeting these cells.

Public health relevance
Project Narrative Full control of the COVID-19 pandemic is hampered by: (i) resistance or lack of access to vaccination; (ii) emergence of new, more infectious viral variants; (iii) “long COVID” symptoms in some patients, including loss of taste and smell, that impact quality of life; and (iv) incomplete understanding of the mechanisms of viral entry. Loss or alterations of taste and smell appear early in disease progression and can occur in the absence of other symptoms, suggesting oral and nasal epithelia as primary viral targets. The goals of this application are to determine whether SARS-CoV-2 primary infection of oral and nasal epithelial cells is necessary for disease and to elucidate the oral and nasal cellular mechanisms underlying taste dysfunction, in order to reveal novel strategies to block infection and prevent and treat long-term symptoms